MRI Phenotyping of Severe BPD and Prediction of Outcomes

SUMMARY
Bronchopulmonary Dysplasia (BPD) is a chronic cardiorespiratory disease of prematurity that is responsible for
the majority of neonatal intensive care unit (NICU) admissions across the nation (approximately $13B/year in
the US for the NICU alone). The disease has high mortality and morbidity, and results in lifelong cardiorespiratory
illnesses that are sometimes diagnosed as asthma and COPD, which themselves comprise an even larger
burden of disease. Survival among extremely premature infants has significantly improved since 1990,
increasing the number of severe cases and the burden of disease. This disease burden disproportionately affects
patients with severe disease, and that is the focus of this renewal proposal. There is a treatment gap that exists
largely because of the paucity of sensitive endpoints for testing in infancy and the justifiable exclusion of the
most severe patients from studies and trials. We have successfully developed free-breathing MRI methods that
even in the most severe patients can safely quantify and define image-phenotypes of disease and predict
respiratory outcomes. These methods have now been translated to clinical practice. We currently follow a cohort
of 257 patients (N=216 severe), who are beginning to turn age 5 in 2024, and have demonstrated very strong
relationships between neonatal MRI and short-and medium-term outcomes. The overall goal of this R01 renewal
is to build on our prior work in neonatal MRI to precisely characterize sequelae of severe BPD in our existing
cohort of patients at school age, evaluate tomographic progression of disease for the first time from NICU to
childhood, create school-age outcomes-prediction models based on neonatal phenotype, and extend functional
MRI (via hyperpolarized Xe and PREFUL) to neonates. In Aim 1 we will use our well-characterized MRI
phenotypes and quantitative measures at infancy to predict respiratory morbidities at school age in the entire
257-patient cohort. In Aim 2 we will precisely measure tomographic disease progression from infancy to school
age, with quantitative and objective measures of regional ventilation, alveolar simplification, gas exchange,
airway abnormalities, and pulmonary vascular disease, via proton and hyperpolarized Xe MRI. Accurate
functional measures remain challenging in the neonatal period, and this is the focus of Aim 3: to perform Xe and
functional proton MRI in neonates with BPD. Preliminary data strongly support each of these Aims. Our previous
R01 led to pioneering work that innovated new MRI techniques and significantly improved patient outcomes
(increased survival, decreased tracheotomy, reduced respiratory readmissions); we will continue this translation
and outcomes improvement via this renewal. By understanding progression of severe BPD with precision and
accuracy, that knowledge can rapidly be translated into precision treatment of individual patients and improved
outcomes at all ages.

Public health relevance
NARRATIVE Bronchopulmonary Dysplasia (BPD) is a chronic cardiorespiratory disease of prematurity that is responsible for the majority of neonatal intensive care unit admissions across the nation, has high mortality, and results in lifelong illnesses that are sometimes diagnosed as asthma and COPD. We have successfully developed free-breathing MRI methods that even in the most severe patients can safely quantify and define aspects of disease and predict respiratory outcomes. The overall goal of this R01 renewal is to build on our prior work in neonatal MRI to precisely characterize severe BPD in our existing cohort of patients soon to be aged 5-7, evaluate progression of disease for the first time from NICU to childhood, create models for the prediction of outcomes, and extend functional MRI to neonates.